Feedback controlled, ultra-high-precision drug delivery

We have demonstrated the first ever example of closed-loop feedback control over plasma drug levels
informed by real-time in-vivo drug measurements. We achieved this using a sensing architecture that is
independent of the chemical reactivity of the target molecule, rendering the approach, at least in theory,
generalizable to any drug. Here we propose a research and development program aimed at translating this
innovative breakthrough into a powerful new tool applicable to both pharmacological research and clinical
practice. By improving (by orders of magnitude) the precision with which we can control in-vivo drug levels, the
proposed technology would render pharmacokinetics an experimentally controllable parameter, allowing
researchers to more precisely map the relationships between pharmacokinetics and clinical outcomes, to
eliminate pharmacokinetic inconsistency as a confounding experimental variable, and to accurately simulate
human pharmacokinetics in animal models. Ultimately, such a technology could be used in the clinic where, by
optimize dosing moment-to-moment in response to a patient's changing metabolism, it would ensure that a
therapy's benefits are maximized while its risks are minimized.

Public health relevance
By providing, for the first time ever, a means of actively and precisely controlling the level of a drug in the living body, the availability of closed-loop feedback-controlled drug delivery could significantly impact both medical research and clinical practice. Such an advance would, for example, enable access to unprecedentedly reproducible pharmacokinetics in research, the accurate simulation of human pharmacokinetics in animal models, and, ultimately, the safer, more effective delivery of drugs to human patients.